Defining the ciliary proteomes in vivo

PROJECT SUMMARY/ABSTRACT
Cilia are complex and dynamic cellular structures crucial for normal development and tissue function. Genetic
disruptions in ciliary proteins lead to a group of human diseases known as ciliopathies, which exhibit a broad
spectrum of phenotypes including early gestational arrest, left-right body axis randomization, cystic kidney, liver,
and pancreas abnormalities, hydrocephalus, neurological and cognitive disorders, blindness, anosmia, and
obesity, etc. The manifestation and severity of ciliopathy disorders vary depending on the specific genetic
mutation and its impact on ciliary function across different cell types and tissues. This variability has prompted
the hypothesis that cilia exhibit distinct functions in various cell types, developmental stages, and environmental
signaling contexts, as well as under pathological conditions and that this is dictated by alterations in the cilia
proteome. Despite the clinical importance of cilia, there is a significant gap in our understanding of cilia functional
roles and the signaling pathways they regulate in most cell types of the body. A key obstacle to advancing our
knowledge of ciliary function is the lack of information on the ciliary proteome composition in different cell types
and how it dynamically changes under varying conditions. This project aims to address this knowledge gap by
developing a novel resource using the promiscuous ligase BirA*G3 fused with the transition zone protein B9d1
in mouse and cell-based models. The transition zone, located at the base of the cilium, serves as a crucial
regulatory gate for controlling the entry and exit of proteins into and out of the cilium. The engineered cells and
mouse lines will enable temporal and cell type-specific biotin labeling of proteins traversing the ciliary transition
zone. Through the utilization of these innovative resources, we will assess the feasibility of this approach both in
vivo and in vitro, with the goal of providing the research community with valuable tools to investigate the dynamics
and diversity of the ciliary proteome. By enhancing our understanding of cilia function at the molecular level, this
research has the potential to uncover novel insights into ciliopathy disorders and pave the way for the
development of targeted therapeutic strategies.

Public health relevance
PROJECT NARRATIVE: Cilia are tiny extensions off most cells of our body that play crucial roles in our development and in maintenance of normal tissue physiology. When proteins in cilia are not functioning properly due to genetic changes, it can lead to a group of diseases called ciliopathies that affect nearly every tissue. The goal of this research project is to generate new genetic tools that can be used to identify proteins that reside in the cilium on different cell types, during different developmental stages, and under disease states to better understand the role of cilia in normal conditions and how they contribute to a wide range of ciliopathy disorders when their function is perturbed.